AQUEOUS HUMOR FORMATION IN PRIMATES

The specific aims are: 1) to measure noninvasively aqueous humor formation rate in primates using fluorophotmetry, 2) to determine the influence of topical adrenergic drugs and role of endogenous adrenergic mediators on aqueous humor formation rate, and 3) to study loss of drug responsiveness in primates undergoing chronic drug treatment. Aqueous humor formation rate will be determined by measuring the anterior chamber elimination coefficient and anterior chamber volume. All measurements of ocular fluorescence will be made with a sensitive fluorophotometer developed specifically for this purpose. The methodology involves initially delivering fluorescein iontophoretically to the corneal stroma and measuring its mass in situ. Fluorescein concentration in the cornea and the aqueous humor will be measured hourly to determine the time course of the exit of fluorescein. A least-squares, computer generated best fit of the data will be used to calculate the anterior chamber elimination coefficient based on a two compartment pharmacokinetic model. The anterior chamber will be photographed with a slitlamp and the dimensions of central, sagittal profiles will be quantitated planimetrically to determine volume. Anesthetized animals will be used initially to permit comparison with results obtained using the invasive methods, constant pressure perfusion and dextran-labeled dye dilution. Subsequent experiments will be performed in unanesthetized, conditioned animals seated in a primate chair. Pharmacological studies will include the effects of Beta-adrenergic agonists and antagonists (eg. epinephrine and timolol) in normal animals and in the same animals following unilateral sympathetic denervation. The rate of formation will be measured in other animals before and after bilateral adrenatectomy and drug effects determined. Various drugs will be continued chronically to determine if their efficacy for reducing aqueous humor formation decreases in the primate model as in glaucoma patients. The long term objectives are: 1) use fluorophotometry to develop a conscious primate model for studying clinical problems associated with aqueous humor formation, 2) study the physiology of formation using adrenergic drugs and determine whether adrenergic stimulation influences normal inflow, and 3) study the loss of hypotension action of adrenergic drugs with chronic use.